The Link: A Collective, Place-Based Approach to Inspiring Missoula's Next-Generation Healthcare Work Force

The Link: A Collective-Impact, Place-Based Approach to Inspiring Montana’s Next-Generation
Healthcare Work Force
Project Summary/Abstract
This project will take a community-based, collective-impact approach to co-creating health-
science and healthy living experiences that are culturally relevant and meet the unique economic and
workforce needs of Missoula and its neighboring rural and tribal communities. Led by PI Holly Truitt
(City of Missoula) and co-I Dr. Rachel Severson (University of Montana), the project will position the
Link, Missoula’s new library-museum complex opening in 2020, as a vibrant Third Place as a hub for
health-science learning, healthy living, and STEM role-model engagement.
The project’s cross-sector advisory group—with representatives from P-12 education, the health
sciences and public health, Montana tribal communities, the social sector, city and county government,
and design thinking—will co-create an array of health learning experiences, including:
 A Community Lab that will embed University of Montana research in the heart of the community.
Emulating best practices developed by the Living Lab (Science World and the University of
British Columbia) and led by co-I Dr. Severson, the Community Lab will: 1) engage high-school
students in independent, mentored research projects; as research assistants in UM behavioral
research conducted at the Community Lab; and as docents and near-peer mentors at the
project’s exhibits and 2) engage early learners as participants in UM behavioral research while
providing positive experiences for children and caregivers with STEM research and role models.
 A DNA Climber exhibit, a health- and genetics-themed climbing structure and interactive exhibit
that responds to community demand for indoor recreation opportunities for children, especially
during Montana’s cold winters and increasingly severe wildfire seasons. The DNA Climber will
provide a space where preschool and elementary learners can move their bodies while learning
about healthy living and genetics.
 Complementary learning tables and pop-up experiences that link UM health-science research to
the DNA Climber exhibit and Community Lab programming.
 Mobile programming to engage P-12 students from rural Missoula County and the neighboring
Flathead Indian Reservation and Bitterroot Valley with the project.
The project aims in particular to reach traditionally underrepresented and underserved groups,
including Native Americans, potential first-generation college students, and children from low-income
backgrounds. External evaluation conducted Inverness Research will assess the impact of the project’s
collective-impact, co-creative design process on STEM and career pathways engagement at the Link.

Public health relevance
The Link: A Collective-Impact, Place-Based Approach to Inspiring Montana’s Next- Generation Healthcare Work Force Project Narrative The project will use a community co-created, collective-impact model to inspire P-12 learners about the health sciences and health career pathways in their community and beyond. With a cross-sector advisory committee, the City of Missoula and the University of Montana will co- create a suite of exhibits, role-model engagement, and research experiences designed to be culturally relevant and to meet the unique economic and workforce needs of Missoula and its neighboring rural and tribal communities. Through an interactive genetics exhibit and climbing structure, pre-school through middle-school students will engage in active living while exploring health-science experiences that complement NGSS standards; the project’s high-school research and docent program will engage students in health-science research while promoting college and career readiness.